Dominantly Inherited Alzheimer Network: Biostatistics Core

Core C: Biostatistics PROJECT SUMMARY/ABSTRACT
The Biostatistics Core (BC) will serve as a resource and collaborator for all projects and cores related to DIAN.
The activities of the Biostatistics Core are designed to enhance and support the research objectives of the
DIAN by providing timely data management and database distribution and appropriate analytic expertise to all
Cores and Projects. The aims of the BC are highly significant because they assure the database and analytic
integrity of all components across the entire DIAN. The BC will achieve these aims by closely interacting with
all other Cores and Projects from the study design to statistical analyses and finally to the publications of
research findings.